Pupillary working memory for adaptive perception

PROJECT SUMMARY
Goal-directed perception and cognition rest on the ability to keep target information activated in mind, through
periods when it is unavailable in the sensory environment. This working memory can serve to track occluded
objects, wield goal templates for visual search, and retain a coherent representation of the visual world as the
eyes move around. Working memory is considered an endogenous internal maintenance function, but
successful behavior must also adjust goals in reaction to external conditions. Likewise, failure to integrate
relevant sensory content into working memory, or to shield internal goal content from interfering input, are both
uniquely characteristic of several neurological and psychiatric disorders. Yet the mechanisms that adaptively
promote or prevent interactions between perception and working memory have been perplexing to isolate, and
it is broadly contested how and where working memory information is stored. In addition to known fronto-
parietal substrates, recent findings show that working memory engages distributed activations throughout
subcortical and sensorimotor regions, and may further recruit the peripheral nervous system and sensorimotor
apparatus. For instance, during a blank working memory delay, gaze and involuntary eye movements veer
toward the location where a working memory item was encoded, and changes in pupil size track its
remembered brightness. Such oculomotor and peripheral measurements have become widely adopted as
indices of neuro-cognitive processing, but it is unknown what underlying activity they reflect and if they serve
any functional role. This proposal tests the possibility that peripheral modulation, and pupil control in particular,
may be a sensitive instrument to align internal goals and perceptual processing. Although the eyes are
considered windows to underlying states, they do more than pass data through—they also modulate and filter
what we extract from the environment. Rather than recapitulate neural activity, pupillary responses may subtly
mold cortical working memory traces, hold the eyes in a goal-ready configuration, or bias visual perception in
line with working memory features. The proposed studies will systematically test these possibilities in humans.
The project will combine physiological measurements (fMRI and eye-tracking) with transcranial stimulation
(TMS), to test the causal relationships between peripheral modulation, neural working memory signatures, and
behavior. Specific Aims will test whether pupillary working memory signals convey behavioral relevance and
decisional quality (Aim 1), configure to the predictive task context (Aim 2), or shape and interact with ongoing
perception (Aim 3). This work will test the boundaries of cognitive influence on pupillary function, revealing new
working memory mechanisms and unboxing potential for pupil states to be volitionally controlled. Every Aim will
perturb activity at critical visuo-oculomotor loci, to dissect the underlying circuitry and define the information
contained within cognitive pupillary inflections. This clarity will be essential in order to harness these integrative
signals toward better methods for gauging and treating sources of visual and cognitive dysfunction.

Public health relevance
PROJECT NARRATIVE The pupils appear as a simple aperture in the eye, but they hold enormous potential to convey information about hidden neuro-cognitive processes—and also to shift or distort visual perception. Irregular pupil response patterns typify several developmental, neurological, and psychiatric disorders, and pupillary readings can objectively gauge the severity of retinal pathologies and cortical blindness. This proposal tests the pupil’s potential to both read out and influence more complex cognitive function in working memory, opening up new frontiers in understanding the pathways between the pupils and brain, the distributed mechanisms of working memory, and the development of tools to both diagnose and treat disorders that have visual symptoms.